Characterization of the TBCEL-dependent Tubulin Degradation Mechanism

Characterization of the TBCEL-dependent Tubulin Degradation Mechanism
Tubulin, polymerized into microtubules, plays a central role in the spatial organization of the cell. In interphase,
microtubules are critical for organelle organization and cellular vesicle transport, while in mitotic cells
microtubules form the mitotic spindle. Tubulin dyshomeostasis has been implicated in cancer, developmental
disorders, and neurodegenerative diseases. Although tubulin is regulated at multiple levels, no dedicated
endogenous tubulin elimination mechanism has been identified. TBCEL is a protein similar to the tubulin
assembly chaperone TBCE, but it lacks tubulin chaperone activity. Instead, TBCEL promotes proteasome-
dependent tubulin degradation. Work from the sponsoring laboratory revealed that TBCEL is highly upregulated
during late erythrocyte development and is critical for the specific elimination of tubulin during erythrocyte
differentiation. I propose to characterize the TBCEL-dependent tubulin degradation mechanism. Proteasome-
mediated protein degradation is usually ubiquitin-dependent. However, ubiquitination can be bypassed if a
substrate-specific proteasome-targeting mechanism exists. Because TBCEL has a ubiquitin-like domain, a type
of domain that often directly interacts with the proteasome, I hypothesize that TBCEL promotes tubulin
degradation by directly interacting with the proteasome, thus bypassing ubiquitination. Thus, I will investigate
how TBCEL couples to the UPS using pull-down mass spectrometry proteomics to identify TBCEL interactors,
biochemical reconstitutions, and cell culture assays to test this “ubiquitin-bypass” model. If this model is not
confirmed, a likely alternative would be that TBCEL promotes tubulin ubiquitination by delivering a ligase to
tubulin. TBCEL also interacts with tubulin and destabilizes tubulin dimers, an activity that I have mapped to the
leucine-rich repeat (LRR) domain of TBCEL. The TBCEL-tubulin binding interface and how TBCEL destabilizes
tubulin is not known, but I hypothesize that tubulin destabilization is required for tubulin to be degraded. For this,
I will characterize the LRR domain-tubulin interaction by protein biochemistry and through structural studies.
Since tubulin is key for many cellular functions, it is important to study the effect of TBCEL’s activity on cells. In
fact, a mutation of the fly TBCEL homolog leads to spermatogenesis defects and infertility. TBCEL’s function in
mammalian testes (spermatogenesis) is not known, but it is expressed at high levels in this tissue. To
characterize TBCEL’s function in this and other nonerythroid tissues, I will use a Tbcel-/- mouse model to perform
histological analysis on tissues of interest. The completion of this project will provide substantial information
about the TBCEL-dependent tubulin degradation pathway and the significance of this pathway for cell biology.
Due to tubulin’s high clinical relevance, researchers are trying to design small-molecule degraders for tubulin.
Thus, our work could inspire translational researchers to develop new ways to target tubulin for degradation.

Public health relevance
Project Narrative TBCEL is a protein that has recently been found in the sponsoring lab to promote proteasome-dependent elimination of tubulin in red blood cells. The overall spatial organization of almost all cells in defined by tubulin, thus the elimination of tubulin is a transformative event for the architecture of the cell. The proposed project aims to understand the mechanism of TBCEL-dependent tubulin degradation pathway.